Genetic Defects in a Novel Radiation Sensitive Syndrome

DESCRIPTION (provided by applicant): The human cells are constantly subjected to genotoxic stresses from both exogenous and endogenous DNA damage agents. Defective response to the DNA damage has detrimental consequence for human health. The goal of this R21 project is to identify the genetic defect in a newly defined radiation sensitivity disease, Dubowitz Syndrome. A skin fibroblast cell line, designated CoDa cells, has been established from a Dubowitz Syndrome patient who displayed severe skin injury after a short course of radiation therapy of cancer. Preliminary studies suggested that the CoDa cells are hypersensitivity to radiation due to a defective DNA repair system, and strongly indicated that there is a previously un-characterized genetic defect in CoDa cells. Combining the results of these preliminary studies and the unique clinical appearance of the Dubowitz Syndrome, it was hypothesized that a new genetic defect is responsible for the radiation sensitivity in CoDa cells. Built on a functional complementation strategy, this R21 project will use a retrovirus based approach to perform a non-biased screen of a cDNA library, to identify the wild type gene whose expression in CoDa can correct the radiation sensitivity. The identification of this gene will provide a novel entry point to decipher additional mechanisms of DNA damage response, and has the potential to identify a new molecular marker for environmental risk assessment and a new target for DNA damage sensitization in cancer therapy. Considering the hypersensitivity to radiation of the CoDa cells, this study will have strong impact on radiation biology and DNA repair fields.

Public health relevance
PUBLIC HEALTH RELEVANCE: Relevance: Historically, identification and characterization of genetic disorders with DNA damage sensitivity syndromes have led to the discovery of many important genes involved in the maintenance of genomic integrity, response to environmental stress, and modulating cancer response to therapeutic DNA damage. This is because these efforts not only result in the identification of the genes directly involved in the disorders, but also provide entry points to decipher a larger network of genes in association with the genetic disorders. This R21 strives to identify a new genetic defect in a hyper- radiation sensitive disease called Dubowitz Syndrome. The outcome would be the identification of a new marker for environmental stress and cancer risk assessment, and a novel target for DNA damage sensitization based cancer therapy. Relevance: Historically, identification and characterization of genetic disorders with DNA damage sensitivity syndromes have led to the discovery of many important genes involved in the maintenance of genomic integrity, response to environmental stress, and modulating cancer response to therapeutic DNA damage. This is because these efforts not only result in the identification of the genes directly involved in the disorders, but also provide entry points to decipher a larger network of genes in association with the genetic disorders. This R21 strives to identify a new genetic defect in a hyper- radiation sensitive disease called Dubowitz Syndrome. The outcome would be the identification of a new marker for environmental stress and cancer risk assessment, and a novel target for DNA damage sensitization based cancer therapy. __SpecificAimsTextDelimiter__ Specific aims: The goal of this R21 exploratory project is to identify the genetic defect in a newly defined DNA damage sensitive Dubowitz Syndrome. Dubowitz Syndrome is a rare recessive genetic disease characterized by a special facial feature, mental retardation, microcephaly, and sometimes cancer development. Recently, we have established fibroblast cell lines from the autopsy of a Dubowitz Syndrome cancer patient, who displayed severe skin sensitivity toward radiation therapy. The cell lines were designated CoDa cells based on the initials of the patient. Preliminary studies have confirmed the hyper-radiation sensitivity of CoDa cells (at 2 Gy of irradiation, the CoDa cells are 27 folds more sensitive than the normal fibroblasts). While CoDa cells clearly have defective DNA repair, they appear to have normal DNA damage signaling immediately following irradiation (such as activations of ATM, DNA-PKcs, p53, and γH2AX), and normal activations of G1/S and G2/M cell cycle checkpoints. A few previously known DNA repair genes appear to be normal in CoDa cells. Our hypothesis is that a genetic defect in CoDa cells is responsible for their hypersensitivity to ionizing radiation. It is likely that Dubowitz Syndrome harbors a unique genetic defect based on our preliminary data and the unique clinical appearance. Because we have characterized the properties of the established CoDa fibroblasts, validated a retrovirus mediated cDNA cloning strategy based on complementation of radiation sensitivity in CoDa cells, we are in a unique position to identify this new gene in DNA damage response. We propose: 1) To use an innovative retrovirus cDNA library based functional complementation screen to identify the gene whose defect is responsible for CoDa cell's sensitivity to radiation. 2) To further characterize the role of this gene in cellular sensitivity to other genotoxic agents. Defective response of human cells to genotoxic stress has detrimental consequence for human health. Historically, genetic characterizations of DNA damage sensitive diseases have played a major role in identifying the genes that are responsible to various genotoxic agents. The identification of this genetic defect will surely facilitate the management of Dubowitz Syndrome. A more significant implication of our study is that it has a great potential to identify a new gene in DNA repair, and to open a new entry point to further reveal the complex DNA damage repair networks. The gene to be identified would be a good candidate for drug targeting to enhance radiation therapy, and a marker for risk assessment for environmental exposures.